INJECTABLE, TUNABLE CO-DELIVERY THERAPEUTIC IMPLANT TO REDUCE AIRWAY STENOSIS

Project Summary
Laryngeal injury, defined as glottic mucosal ulceration or granulation or subglottic granulation/stenosis, leads to
respiratory failure and requires intensive care unit (ICU) admission. More than 55,000 adults are treated daily in
ICUs and 13-20 million worldwide require intubation each year. Current treatment often requires multiple
surgeries with or without tracheostomy. Recently, adjuvant glucocorticoid use has been reported, as they are
known to improve airway inflammation. However, these treatments require repeated injections with an interval
varying from every week to 5 weeks with a total of 3 to 25 injections, which is a significant burden to the patients.
Therefore, there is a critical unmet need in delivering glucocorticoid non-invasively in a dose-controlled manner
to the lesion. In addition, investigation into the tracheal microbiome suggests a contributing role of
laryngotracheal microbiota to mucosal inflammation and the pathogenesis of tracheal stenosis. We will develop
a novel injectable co-delivery implant that can deliver glucocorticoid and antimicrobial over time either in a
sustained release fashion or in a laser-light activated approach effectively for 6 weeks in a leporine preclinical
model. Our in vivo preliminary work showed minimal immune responses from the injectable implant in the
leporine upper airway after 6-week implantation. In the first aim, we will optimize our injectable co-delivery implant
drug delivery system for the ex vivo trachea tissues and measure any local immune response in healthy leporine.
In the second aim, we will employ the implant in a trachea injury model to quantify its healing impacts compared
to no treatment or single glucocorticoid and antimicrobial injections. Simultaneously, the upper respiratory
microbiome will be analyzed to determine the microbiome changes and the efficacy in reducing bacteria utilizing
our implants compared to a single glucocorticoid injection. This work lays the foundation for optimized, dose
controllable therapeutic delivery to the airway and improved drug delivery.

Public health relevance
Project Narrative Airway stenosis resulting from various reasons including but not limited to endotracheal intubation, tracheostomy, autoimmune diseases and infection is challenging to treat because prolonged intubation often leads to high risk of respiratory and vocal dysfunction. This project aims to quantify improvements in wound healing and tissue biomechanics for airway stenosis using a novel dose-controllable, injectable therapeutic delivery loaded with corticosteroid and antimicrobial. The long-term goal of this research is to develop a platform to optimize wound healing of the airway through novel drug delivery approaches.